Developing a new aspiration catheter solution for the treatment of large and medium vessel occlusions

Project Summary/Abstract
Stroke is the leading cause of serious long-term disability and accounts for 4.6 million disabled people in the
United States. Stroke-related costs total over $46 billion in the United States each year.1 Of the nearly 800,000
Americans who have a stroke per year, 87% experience ischemic stroke1, of which 49%-86% are attributed to
either large vessel occlusions (LVO) or medium vessel occlusions (MeVOs).2,3 Mechanical thrombectomy, via
a stent retriever or aspiration catheter, is now the standard of care for eligible patients who experience
ischemic stroke.4–6 While mechanical thrombectomy has progressed dramatically over the past few years,
existing aspiration catheter devices suffer from significant limitations. Major challenges to successful treatment
of ischemic stroke include quickly navigating to the clot and fully capturing it in the first pass while avoiding
thrombus breakage and further downstream ischemia. This project has two aims to address existing limitations
of aspiration thrombectomy. The first aim develops, builds, and tests a prototype aspiration catheter with an
adaptive radially expandable tip. This expandable tip is intended to improve clinical outcomes for all patients
treated with mechanical thrombectomy due to its improved access and navigation capabilities and enhanced
first pass effect (FPE). The second aim tests the efficacy of the novel aspiration catheter using an in vitro
model. This project will lead to the development of a device intended to improve safety and efficacy by
alleviating multiple pass attempts, clot fragmentation, and vessel injury. Through these goals, this project has
the potential to improve the clinical outcome of patients who suffer from ischemic stroke by propelling the field
of neuro-interventional treatments forward.

Public health relevance
Narrative Of the nearly 800,000 Americans who have a stroke per year, 87% experience ischemic stroke.1 This project will assess the safety and efficacy of the aspiration catheter with a patient-adaptable radially expandable tip, which may improve clinical outcomes of large vessel occlusion (LVO) and medium vessel occlusion (MeVO) treatment due to improved access, navigation, and clot digestion.7 These studies will provide the basis for improved mechanical thrombectomy techniques and technology for the treatment of LVO and MeVO ischemic stroke.